Biomedical Research Excellence, Epigenomics of Development and Disease

UNIVERSITY OF NORTH DAKOTA
EPIGENOMICS OF DEVELOPMENT AND DISEASE
ADMINISTRATIVE CORE
SUMMARY
The goal of the Administrative Core is to promote the growth and success of the COBRE centered on the
Epigenomics of Development and Disease by consolidating, centralizing and managing all necessary
resources. The core will support investigators whose work focuses on mechanisms underlying epigenetic
changes in models of development and disease. To ensure success of our researchers and promote long-term
sustainability and growth of our program, we will provide administrative and/or financial support for essential
aspects of our group’s activities. These include the following: (1) Implement a comprehensive and
individualized Mentoring Program for our Project Leaders at multiple stages of their careers, (2) Provide
oversight and evaluation of the Mentoring Program through the Internal Advisory Board, External Advisory
Board, and UND Department of Education Resources, (3) Fund new research projects centered on epigenetics
of disease and development though Pilot Grant support, (4) Recruit new investigators whose research is
focused on understanding epigenetic mechanisms using unique model systems of diseases, (5) Provide
structured opportunities (e.g. seminars, symposia) to establish and facilitate productive scientific interactions
within the group, (6) Enhance the wider epigenetics community at UND through continuation of epigenetics-
themed seminars and symposia, (7) Raise the national profile of the epigenetics group, (8) Provide
administrative support for the Genomics Core and its associated training activities, and (9) Foster increased
collaborations with other UND and regional groups including UND COBRE, ND INBRE, DACCOTA, etc.
These functions will enhance our ability to execute innovative, high-quality research that will lead to increased
understanding of epigenetic mechanisms in pathophysiological conditions, with the potential for future
therapeutic and clinical applications.